CHOLESTEROL METABOLISM IN PLASMA LIPOPROTEINS AND LIVER

To determine how cholesterol and phosphatidylcholine (pc) are metabolized in the liver and how pc is transported between the tissues, blood, and bile in normal people and in various diseases.